Illuminating tetrahydrocannabinol signaling in the brain’s reward circuitry with in vivo photopharmacology

Project Summary/Abstract
9-tetrahydrocannabinol (THC) is the main psychoactive compound in marijuana, acting on CB1 cannabinoid
receptors (CBRs) in the brain. Marijuana use is increasing in the United States, yet its role as an addictive drug
is controversial. Excessive use can cause cannabis use disorder, and some research suggests that marijuana
is likely to precede the use of other illicit drugs. However, our understanding of the mechanisms by which THC
affects the brain is confounded by widespread CB1 receptor expression and the ability of THC to activate other
cannabinoid receptor subtypes expressed in overlapping circuits. Much of the field's prior work with THC has
relied on systemic injection to rodents or THC wash-on to acute brain slices; these approaches cannot pinpoint
the location of CBRs or downstream signaling mechanisms activated by THC. To deconvolute the effects of
THC in the brain's reward circuits, there is a critical need for new tools to acutely manipulate THC with
enhanced spatiotemporal precision. The applicant's long-term goal is to identify the molecular mechanisms by
which THC affects brain reward circuits and illuminate the role of THC in addictive behaviors. To this end, they
developed a photo-switchable THC analog containing an azobenzene photoswitch (azo-THC) that can be
isomerized between active and inactive configurations using two different colors of light. This allows THC
activity to be turned ON and OFF in a reversible manner. To enhance azo-THC's spatial precision in vivo, they
also developed THC photoswitch that can be targeted to specific cells or membranes using genetically
encoded protein tags (PORTL-THC). Preliminary results demonstrate the feasibility of these tools to reversibly
control THC activity with light; however, their application has so far been limited to CBR-overexpressing cell
lines. The overall objective of this proposal is to validate the ability of azo-THC and PORTL-THC to reversibly
manipulate CBR signaling in cultured neurons and in vivo. The tools will be benchmarked against existing
approaches in two interwoven but independent specific aims: 1) Optical control of THC-signaling on cultured
neurons and in vivo; 2) Engineer PORTL-THC for cell-specific modulation of THC-activity. These aims will
validate the utility of these optical tools to modulate THC activity in neurons, and then map the local effects of
THC in the mesolimbic circuit during behavior. This proposal has a strong scientific premise built on rigorous
preliminary data, our published studies, and a careful review of the literature. It is innovative because it will
generate state-of-the-art tools to target CBRs on specific neuron populations in freely moving mice. The
completion of these aims will have significant impact by advancing our knowledge of THC actions in brain
reward circuits, and will increase our understanding of the molecular mechanisms that underlie widespread
psychiatric disorders, such as addiction.

Public health relevance
Project Narrative Δ9-tetrahydrocannabinol (THC) is the main psychoactive component of marijuana, acting on cannabinoid receptors in the brain. Excessive THC use can cause cannabis use disorder, yet the underlying mechanisms are poorly understood due to the widespread expression of cannabinoid receptors throughout the brain's reward circuits. This proposal aims to develop technologies that use light to manipulate THC on specific cell populations during mouse behavioral experiments, which will both help researchers deconvolute THC effects in reward processing and illuminate THC's potential as an addictive drug.